Ensuring Safe and Effective Delivery of Outpatient Parenteral Antimicrobial Therapy for Veterans

Background: Every day, hospitals across the United States (US) and Veterans Health Administration (VHA)
discharge patients with vascular access devices for outpatient parenteral antimicrobial therapy (OPAT). OPAT
has advantages but it is not risk-free and can result in adverse events and hospital readmissions. A high
degree of commitment and task performance by patients and caregivers is also required. A 2020 VHA
Antimicrobial Stewardship survey found variability in who monitors OPAT patients and that most facilities use
outside contract services, which may make it difficult to coordinate care across settings. OPAT is a vital part of
Veteran care, yet we know very little about how it is managed across VHA or the challenges Veterans and
their caregivers face while receiving at-home therapy.
Significance: This research will advance knowledge and improve care delivery by addressing VHA and
research clinical and methods priorities related to quality and safety, the use of cross-cutting methods and
real-world impact. This work is also aligned with VA strategic goals and core principles, including providing
Veterans with care in their homes when needed and the required training and resources for their caregivers.
This research will advance knowledge and lead to improvements in quality and safety, a VHA clinical priority,
by identifying and deploying strategies to ensure safe and effective OPAT delivery for Veterans.
Innovation & Impact: This study is the first comprehensive assessment of OPAT delivery in VHA. Findings
will lead to improvements in OPAT delivery and provide knowledge for improving home infusion therapy more
broadly. Focusing on the patient journey, we will highlight the interactions across different socio-organizational
contexts, providing a more complete view of care delivery. Innovative methods that actively engage Veterans,
caregivers and clinical providers are used throughout the research process. We will also use a collaborative
co-design approach to bring stakeholders together to develop interventions that are more acceptable and
feasible to implement. Methods that could be used to address other care delivery challenges.
Specific Aims: Aim 1: Assess how OPAT is delivered by VHA Medical Centers, through semi-structured
interviews with clinical providers at selected facilities followed by a survey of all VHA medical centers. Aim 2:
Gain an in-depth understanding of the Veteran home experience using video-reflexive ethnography and photo
elicitation followed by a survey assessment of Veteran experiences with a broader sample of OPAT patients.
Aim 3: Design interventions to enhance OPAT safety and delivery in collaboration with Veterans, their
caregivers and clinical care providers.
Methodology: This study uses qualitative and quantitative methods to understand how OPAT is delivered
across VHA, how patients and caregivers experience at-home OPAT and a user-centered design approach to
develop interventions to address OPAT-related challenges and safety concerns. Our research is guided by the
Systems Engineering Initiative for Patient Safety (SEIPS) 3.0 framework, which incorporates the patient
journey across various care settings. We will conduct semi-structured interviews and surveys of clinical care
providers involved in OPAT care, and video-reflexive ethnography, photo elicitation, and surveys with Veterans
and caregivers. Analyses of these data will be aligned with the SEIPS framework and used to inform the co-
design of interventions with Veterans, caregivers and providers to address OPAT challenges and needs.
Next Steps/Implementation: Outcomes from this work will include a detailed understanding of OPAT use and
delivery across VHA and an understanding of the patient experience at hospital discharge and post-discharge.
Top priority interventions to support in-home OPAT delivery along with implementation steps will be identified.
Protocols for using novel methods and co-design to collaborate with healthcare professionals and patients will
also be developed. Importantly, this work will inform OPAT related policy and practice within VHA.

Public health relevance
Every day, Veterans across the Veterans Health Administration (VHA) are discharged home with vascular access devices for delivery of outpatient parenteral antimicrobial therapy (OPAT). Although OPAT is a vital part of Veteran care, we know very little about how it is managed or the challenges Veterans and their caregivers experience. Because adverse events are possible, this information is critical to identify gaps in care and develop strategies for Veterans to receive safe, effective therapy. This study engages Veterans, caregivers and clinical care providers using multiple methods including semi-structured interviews, surveys, video reflexive ethnography, and photo elicitation to gain a deeper understanding of the challenges encountered related to the delivery and administration of at-home OPAT. We will also engage these stakeholders in a collaborative co-design process to develop interventions for improving OPAT care and management at home. Importantly, this work will inform OPAT related policy and practice within VHA.